DRUG METABOLISM IN LUNG CANCER

The objective of this case controlled study in lung cancer is to determine if phenotypic measures of drug metabolizing activity as measured by the Pittsburgh drug cocktail in the whole body or from quantitation of mRNA for individual drug metabolizing enzymes in lung parenchyma, bronchial mucosa or lung tumor will be related to the risk of developing lung cancer. Measures of drug metabolizing activity will also be related to specific mutations and oncogene amplification as well as the biological behavior of the tumor.